Mayo Clinic Multiple Myeloma SPORE

PROJECT SUMMARY/ABSTRACT
The Mayo Clinic Multiple Myeloma SPORE (SPORE) is a dynamic, productive, translational cancer research
program based at all three Mayo Clinic sites (Rochester MN, Jacksonville FL, Phoenix AZ), now with input from
the Princess Margaret Cancer Centre in Toronto, Ontario. From 2003-2013 we participated in the joint
DFCI/Mayo Clinic Multiple Myeloma SPORE, and since 2015 in the Mayo Clinic Multiple Myeloma SPORE. At
the center of the ongoing success of the SPORE is the collaborative interaction between investigators
throughout the Mayo Foundation, as well as SPORE basic laboratory, translational and clinical investigators
and patient advocates focused on MM. The overall goal of the SPORE is to support innovative, interactive,
rigorous translational myeloma research that leverages the expertise of laboratory, translational and clinical
expertise. Over the last funding period, the SPORE has been highly productive as demonstrated by
identification of new tumor markers and prognostic indices that are being used clinically; scientific findings that
led to innovative clinical trials both within and outside the SPORE; multiple publications with many authored by
investigators from multiple sites; and brisk accrual to translational clinical trials. The SPORE was involved in
multiple productive vertical and horizontal collaborations with other national and international academic
institutions and organizations. For example, with leadership of clinical efforts in patient-focused clinical trials
from the Multiple Myeloma Research Foundation, International Myeloma Foundation, and MyelomaCrowd. The
current proposal includes 3 major research projects. Two of the projects are new, based on research results
obtained over the past funding period, while Project 1 is a continuation of efforts to investigate ways of
modulating the immune micro-environment to improve the efficacy of oncolytic viral therapy in MM in a phase I
clinical trial. Project 2 is an integrated multi-omic analysis of high-risk MM with associated clinical trial highly
focused on identifying promising approaches in this group of patients that have not benefited from recent
advances. Project 3 is investigating the genetic and microenvironmental mechanisms of progression of
smoldering MM to MM to enable early detection of MM requiring treatment. The SPORE also includes
Developmental Research and Career Enhancement Programs to pursue novel translational concepts in MM
research and new investigators through the programs respectively. Finally, the SPORE will enhance the
infrastructure that supports translational MM research through shared core resources in Administration,
Biostatistics & Bioinformatics, and Biospecimens & Clinical Database.

Public health relevance
PROJECT NARRATIVE The Mayo Clinic Multiple Myeloma SPORE is a highly productive research program based at the NCI- designated Mayo Clinic Comprehensive Cancer Center located in Minnesota, Florida and Arizona and the Princess Margaret Cancer Centre in Toronto, Ontario. The goal of the SPORE is to support investigators at all three sites with expertise in basic myeloma biology, genetics, clinical research and epidemiology as they work together to translate basic science advances into improved care for myeloma patients. SPORE research projects focus on oncolytic virotherapy, the myeloma tumor microenvironment, myeloma immunotherapy, early detection of myeloma requiring treatment, prevention of myeloma progression, and using genetics to optimize therapy of high-risk myeloma.